Improving Diabetes Health in Emerging Adulthood Through an Autonomy Supportive Intervention.

Project Summary
This project will use the multiphase optimization strategy (MOST) approach to test the efficacy of an autonomy
supportive behavioral intervention to improve metabolic control among older adolescents and emerging adults
(16-25) with T1D. Youth this age demonstrate chronic poor metabolic control that persists into adulthood
leading to the premature emergence of short- and long-term diabetes complications. Developmentally,
adolescence and emerging adulthood is a time when the need for independence and autonomy are particularly
salient. This new intervention will leverage youths’ desire for autonomy by designing an intervention to
support diabetes self-management autonomy. This intervention is guided by self-determination theory (SDT)
which suggests that autonomous (i.e., self-initiated, driven by intrinsic versus extrinsic motivation) diabetes
management depends upon three conditions: 1) the perception that one’s behavior is self-directed, 2) feelings
of competence, or self-efficacy, and 3) the existence of caring relationships supportive of the behavior. We have
identified three intervention components that target the SDT constructs. A question prompt list (QPL) is a
simple, inexpensive tool comprised of a list of questions that patients might consider asking their health care
provider during a clinic visit. QPLs empower patients to assume a more active role (asking questions and
stating concerns) during clinic visits. The Motivation Enhancing System (MES) is an eHealth intervention to
increase intrinsic motivation for health behavior change. MES content is based on the Motivational
Interviewing (MI) framework and the Information-Motivation-Behavioral Skills (IMB) model of health
behavior change which posits that behavior change results from the joint function of three critical components:
accurate information about risk behaviors or their replacement health behaviors, motivation to change
behavior, and behavioral skills necessary to perform the behavior (self-efficacy). Text message reminders
(TXT) are a strategy to encourage youth to complete their diabetes self-care that also lead to gains in self-
efficacy and a stronger relationship with diabetes care providers through greater communication and
satisfaction. We will test the efficacy of these intervention components toward improving metabolic control in a
component selection experiment (N=320). The experiment will use a factorial research design with random
assignment to determine which intervention components contribute to a clinically significant improvement
(≥0.5%) in HbA1c. The result of this research will be an optimized, multi-component intervention with effect
size estimates that will be used to inform a large scale, fully powered effectiveness trial. This theory-driven
intervention will be scalable to a variety of chronic illness contexts and the knowledge gained from this
research will inform self-determination theory and behavioral interventions targeting this population (for
which there currently are none).

Public health relevance
Project Narrative This project will test the efficacy of a multi-component behavioral intervention to improve metabolic control among older adolescents and emerging adults (16-21) with T1D, a group with chronic poor metabolic control. This intervention is grounded in self-determination theory which states that a youth who believes their diabetes management is self-directed, competent, and supported by others is more likely to consistently complete their diabetes self-care. This theory-driven intervention will be scalable to a variety of chronic illness contexts and the knowledge gained from this research will inform self-determination theory and different interventions targeting this population (currently there are no interventions that directly target emerging adults).